2022 Metals in Medicine Gordon Research Conference

PROJECT SUMMARY/ABSTRACT
The mission of the Metals in Medicine Gordon Research Conference (GRC) is to cultivate a community of
multidisciplinary scientists focused on improving human health by translating basic science discoveries in the
areas of bioinorganic chemistry, materials, and inorganic nanotechnology to medical application. The 2022
Metals in Medicine GRC will bring together more than 150 scientists and clinicians from around the world in
academia, industry and government to discuss the latest developments in the field in the intimate and informal
environment of a GRC. The organizers have three specific aims: 1) Showcase how the properties intrinsic to
metals and inorganic materials can be leveraged to develop transformative new chemical and nano-scale entities
for use in the diagnosis, imaging, and treatment of disease; 2) Highlight the development of new systems and
optimization of existing technologies to aid in understanding the roles of metals in the pathological basis for
disease and medical treatments; 3) Provide a stimulating and dynamic gathering to engage and inspire young
scientists in this evolving field.
The theme of the 2022 meeting is “Advancing the use of metal-based compounds and nanotheranostics for
personalized medicine.” Aim 1 is addressed by emphasizing the unique features of metals to support human
health. Several sessions mix basic science with advanced pre-clinical and clinical evaluation. The program opens
with Supramolecular Coordination Complexes for Biomedical Applications, which will feature the latest
innovations in nanoscience as it relates to self-assembling molecular systems and nanomaterials as
theranostics. Novel Chelation Strategies and Applications for Radionuclides and Contrast Agents focuses on
stably complexing metals to bioconjugates for diagnostics (PET and MRI), and for targeted radionuclide therapy.
There will be two sessions on metal-based therapeutics (Stimuli-responsive Materials for Therapy and Imaging
and Targeted Metal-based Therapeutics). Clinical Advances for Metals in Medicine will discuss metal-based
diagnostics and therapeutics that are in early human trials. Aim 2 is achieved with sessions focusing on basic
research and early development of new technologies. The role of specific metals in the etiology of disease will
be presented in the session Essential Metals in Disease Mechanisms, and the emerging area of Catalysis in
Cells highlights advances in this traditional application of metals in an untraditional environment. Novel
Metallomics Methods and Tools presents approaches and technologies to detect, quantify, and trace metals and
inorganic materials. The Early Career Investigators/Emerging Topics session will complete the program, and
supports Aim 3, with an emphasis on encourage early career investigators. Speakers will also be selected from
the submitted abstracts, achieving 25% representation from early stage scientists and ensuring that the most
exciting new discoveries are presented. Other program features focused include “Poster Previews”, the “Power
Hour” to address issues around career advancement for STEM women scientists, and many informal activities.

Public health relevance
NARRATIVE The 2020 Metals in Medicine Gordon Research Conference is a unique forum for graduate students, post- docs, and other scientists to present and exchange new data and cutting-edge ideas on discoveries in metal- based diagnostic and therapeutic agents, and how metals are involved in disease. The speakers will range from emerging to established scientists, with poster sessions and other forums for scientific and social interaction of trainees with investigators in academia, industry, and government.